Aldosterone Independent Activation of the Mineralocorticoid Receptor via IL-6 and Rac1 Induces Sodium Retention and Hypertension

Project Abstract
The goal of this proposed project titled “Aldosterone Independent Activation of the Mineralocorticoid
Receptor via IL-6 and Rac1 Induces Sodium Retention and Hypertension” is to investigate the role of renal
dendritic cells (rDCs) in mediating cytokine-induced transactivation of the mineralocorticoid receptor (MR),
increasing sodium (Na+) reabsorption and blood pressure (BP). Excessive Na+ reabsorption is a main cause of
hypertension and end organ damage. The mechanisms mediating pathophysiological Na+ retention are
unknown; however, increased inflammation and excessive activation of distal nephron Na+ transporters, the Na+
chloride cotransporter (NCC) and the epithelial Na+ channel (ENaC) play a role. However, the mechanisms
linking increased inflammation and cytokines to Na+ transporter activation are yet unidentified.
Following a stressor, DCs cells secrete interleukin 6 (IL-6) producing a pro-inflammatory milieu. Our
preliminary data suggest that baseline blood pressure (BP) is regulated via rDCs, and the decreased systolic BP
levels observed in rDC-depleted mice may be due to decreased NCC protein expression. Further, our data
suggest that hypertension (HTN) increases serum IL-6 levels, while renal cortical IL-6 mRNA levels are reduced
in rDC-depleted mice. Our robust in vivo data suggest that intrarenal IL-6 infusion increases phosphorylated
(pT53) NCC, and total NCC, as well as ENaC expression. We also show that systemic IL-6, plus high salt (HS,
4%) increases BP after 3 days. Together, these data strongly support a role for rDC-mediating local IL-6 levels,
and IL-6 increasing Na+ transporter expression and/or activity and BP.
Moreover, our in vitro data demonstrates that IL-6 induces MR nuclear translocation and activation of
downstream mineralocorticoid response elements (MRE), via the small GTP-ase Rac1 and reactive oxygen
species (ROS) generation, and can directly activate thiazide-sensitive Na+ transport. Thus, we hypothesize that
intrarenal IL-6 transactivates the MR, increasing distal tubular Na+ reabsorption via NCC and ENaC leading to
hypertension. The studies in this proposal, when completed, will demonstrate that: 1) salt-sensitive HTN
activates rDCs, 2) rDCs contribute to increased intrarenal IL-6 levels during salt-sensitive HTN, 3) IL-6
independently transactivates the MR and 4) rDC-mediated IL-6 secretion increases NCC and ENaC Na+
transport leading to HTN.

Public health relevance
Project Narrative The central goal of this proposed work is to understand the role of inflammation in mediating increased sodium (Na+) reabsorption during hypertension (HTN). This work will elucidate mechanisms involved in IL-6 induced mineralocorticoid receptor (MR) activation, via renal-specific dendritic cells (rDCs) during salt-sensitive L-NAME HTN and allow for new avenues for exploitation of possible therapeutic options. Reducing Na+ reabsorption will decrease blood pressure and end organ damage.